Interindividual Variability in Drug Metabolism in Ethnically Diverse Populations

Differences in drug metabolism between patients can significantly affect drug concentrations in the body and overall drug response (efficacy and toxicity). Advances in pharmacogenomics have improved our understanding of how variations in genes that encode drug metabolizing enzymes (e.g., cytochrome P450 enzymes) affect drug response. However, far less is known about the mechanisms and clinical consequences of genetic and non-genetic factors (biological sex, age, epigenetics, drug interactions, etc.) that affect drug disposition in patients from all backgrounds. Adequate representation of the U.S. population in both basic and translational pharmacogenomics and multi-omics studies is key to the implementation of precision medicine for all patients. Recent findings from my laboratory support the contention that genetic and phenotypic markers are needed to accurately assess individual drug metabolism capacity. The overall vision of my research program is to understand the underlying mechanisms of interindividual variability in drug metabolism and drug response to advance precision medicine for all patients. Through this Maximizing Investigators’ Research Award (MIRA R35) for Early Stage Investigators, my research program will address key questions and important challenges in the field through the following distinct and complementary projects. Project 1 will test the hypothesis that including people from different genetic backgrounds in pharmacogenetics studies will provide greater insight into the underlying mechanisms of interindividual variability in drug metabolism and response. Project 2 will test the hypothesis that the application of an integrated pharmaco-omics approach will greatly enhance the ability to precisely quantify drug metabolism capacity in individual people. Project 3 will test the hypothesis that the incorporation of data from mechanistic drug metabolism studies with genetically different populations will improve the prediction of pharmacokinetic variability using data-informed physiologically based pharmacokinetic models compared to model predictions using “reference” populations. Significance: This research promises to shift the current “one-size-fits-all” drug dosing paradigm by utilizing and integrating population-specific genetic variants and phenotypic biomarkers to accurately quantify individual drug metabolism capacity, a major predictor of drug response. My research program will increase the return on investment for precision medicine initiatives by overcoming the barriers that have limited the applicability of genotype-guided dosing. This work will lay the foundation needed to implement the right drug at the right dose for the right patient at the right time. This research represents the first comprehensive pharmaco-omics investigation in representative populations to utilize germline genetic markers as well as dynamic epigenomic, proteomic, and metabolomic biomarkers to capture drug metabolism phenotype. I am dedicated to mentoring the next generation of drug metabolism scientists.

Public health relevance
The goal of this proposal is to improve our understanding of how genetic and non-genetic factors affect drug metabolism and drug response in patients from different genetic backgrounds. This research is important to individualize drug treatment for patients to maximize beneficial drug effects (efficacy) and minimize serious side effects (toxicity). This work will lay the foundation needed to implement precision medicine for U.S. patient populations to achieve the right drug at the right dose for the right patient at the right time.